Mapping the non-coding RNA landscape in skeletal muscle health and disease

Project Summary
Skeletal muscle tissues are developed and maintained through the coordinated action of myogenic and non-
myogenic cells. Dysregulation of myogenic cell identities and functions are commonly observed in skeletal
muscle disease. Facioscapulohumeral muscular dystrophy (FSHD) is the second most common inherited
muscular dystrophy and results in progressive muscle weakness without any effective therapies. Numerous
cellular etiologies are observed in FSHD, such as loss of myogenic cells, including muscle stem cells and
myofibers, and increased fibrogenic, adipogenic, and immune cells. The most common form of FSHD arises
from aberrant expression of the DUX4 gene caused by epigenetic de-repression of the D4Z4 locus. DUX4
expression in FSHD individuals is regionally varied and highly sporadic within skeletal muscle tissue. Notably,
DUX4 expression is both induced by and has pathogenic mechanisms related to noncoding RNAs (ncRNAs).
Noncoding RNAs (including miRNAs, lncRNAs, snoRNAs, and eRNAs) are critical regulators of skeletal muscle
cell identities and functions in health and diseases and act through modulation of transcriptional networks.
Comprehensive understanding of ncRNA networks and mechanisms is lacking due to a paucity of ncRNA
profiling technologies. Conventional single-cell and spatial RNA-sequencing technologies preferentially detect
polyadenylated, protein-coding mRNAs, and do not efficiently capture most ncRNAs due to their lack of
polyadenylation. In this proposal, we will apply a new RNA mapping technology called STRS-HD that is uniquely
capable of efficiently and comprehensively detecting the total transcriptome, including both polyadenylated and
non-adenylated transcripts, with single-cell spatial resolution to reveal global ncRNA expression heterogeneity
in diverse cell types within skeletal muscles. We will leverage this new spatial total RNA-sequencing method to
broadly interrogate noncoding RNAs in healthy skeletal myogenesis and in FSHD pathogenesis. In Aim 1, we
will implement this total transcriptomic method to investigate how noncoding RNAs impact cell fate regulation
adult skeletal muscle regeneration in mice. We will explore cell type-specific ncRNA expression variation and
use spatial transcriptomics to map ncRNA features onto spatially resolved cell-cell communication interactions
to provide insights into ncRNA regulation of myogenic cell fates. In Aim 2, we apply these methods to resolve
how ncRNAs vary in FSHD pathologies using two mouse models subject to DUX4 anti-sense oligonucleotide
therapy. We will integrate spatial total transcriptome maps with histopathology to reveal ncRNA determinants of
altered myogenic cell specification and myofiber damage in FSHD. In Aim 3, we will extend the STRS-HD
approach to human FSHD biopsies and compare ncRNA features to unaffected familial controls and contrast
spatial ncRNA maps to cell-free RNA-sequencing in donor plasma to identify new total RNA biomarkers of FSHD.
These new total transcriptomic technologies will be broadly applicable to the study of ncRNAs in developmental
and disease biology of skeletal muscle and other tissues.

Public health relevance
PROJECT NARRATIVE Skeletal muscle health depends on the coordinated function of various muscle cell types during homeostasis and in response to injuries. In disease settings, such as facioscapulohumeral muscular dystrophy (FSHD), muscle cell identities and functions are altered due to dysregulation of both protein-coding and non-protein coding genes. We will investigate the role of non-protein coding genes, which are poorly detected by standard methods, through new genomic technologies that uniquely detect the complete RNA transcriptome in healthy and FSHD muscles and blood.